Mentoring in Endocrine and Metabolic Abnormalities in HIV and Aging

Project Summary
Todd Brown, MD, PhD, a Professor of Medicine and Endocrinology in the Division of Endocrinology, Diabetes,
& Metabolism at Johns Hopkins University, submits this application to renew his K24 Mid-Career Development
award in order to continue to provide protected time to mentor trainees in patient-oriented research (POR) in
HIV Endocrinology. Dr. Brown is one of the few endocrinologists worldwide specializing in endocrine and
metabolic disorders in people living with HIV. He will pursue additional training to expand his research program
to support a wider range of early investigators in both the US and abroad. Candidate: Dr. Brown is a highly
productive clinical researcher in the HIV Comorbidities field. Since 2004, he has been continuously NIH-funded
to investigate the epidemiology, pathogenesis, and clinical management of endocrine and metabolic
dysfunction in individuals with HIV, using long-standing, NIH-supported infrastructure as a platform for his
investigations, including the MACS WIHS Combined Cohort Study (MWCCS), the AIDS Linked to the
IntraVenous Experience (ALIVE) cohort, and the AIDS Clinical Trials Group. With his uncommon skill set and
strong POR program in endocrine and metabolic complications in HIV, he has been a sought-after collaborator
and mentor at Johns Hopkins and at institutions from around the country. Mentoring Plan/Environment: This
application will leverage the extensive training resources at Johns Hopkins, including the Center for AIDS
Research, the Institute for Clinical and Translational Research, and K12/T32 training grants in a variety of
specialties. It draws on the unparalleled resources of the MWCCS and other funded studies to serve as a
platform for POR trainees at multiple levels. Research Plan: The novel research supported by this K24 award
will make a significant contribution to the understanding of the causes and consequences of endocrine and
metabolic abnormalities in HIV-infected persons in three major areas: 1) Osteoporosis and Fracture Risk, 2)
Hypogonadism, and 3) Insulin Resistance. It will build on ongoing work in the MWCCS, explore new
hypotheses, and expand opportunities for trainees.

Public health relevance
Todd Brown, MD, PhD is an endocrinologist and epidemiologist at Johns Hopkins University whose primary research and clinical interest over the last 20 years has focused on the causes and consequences of endocrine and metabolic dysfunction in persons living with HIV. This career development award renewal will provide additional training and continue to provide protected time for him to mentor trainees interested in patient-oriented research in the HIV Comorbidity field.